Targeting Unfolded Protein Response (UPR) to improve fracture repair in obesity

ABSTRACT
Skeletal fragility and fracture risk are emergent co-morbidities in individuals with obesity. Poor fracture outcomes,
more apparent in obese subjects with diabetic complications, prolong disability and increase medical costs.
However, the underlying mechanisms are unknown. Bony callus formation is a ‘high-demand’ phase of fracture
repair that is reliant on Wnt signaling as well as increased protein synthesis, folding, and processing by the
osteogenic cells. The Unfolded Protein Response (UPR) regulates cellular protein synthesis and facilitates
correct protein folding in the endoplasmic reticulum (ER), thus aiding adaptation to environmental and/or
metabolic changes. ER stress and aberrant UPR, due to protein folding and processing overload, are pivotal
mediators of obesity related co-morbidities. Although ER stress has been linked to adverse skeletal outcomes
in some preclinical studies, the functional contribution of transcriptional and translational response arms of the
UPR in osteogenesis remain unresolved. We found compelling evidence that obesity augmented adiposity but
repressed transcription of the pro-osteogenic adaptive UPR targets, protein synthesis and viability of the callus
during the osteogenic phase of fracture repair. A faction of skeletal stem cells known as Cxcl12-abundant
reticular (CAR) cells, exhibited ‘translational arrest’ gene signature, a known pro-adipogenic attribute, despite
increase in their incidence with obesity. Notably, the chemical chaperone TUDCA, that modulates UPR by
improving protein folding, rescued the obesity-related osteo- to adipocytic skewing of the callus underscoring the
therapeutic potential of modulating this process in bone repair. In parallel studies we discovered that the UPR
sensor, IRE1, is the principal driver of adaptive UPR, promotes Wnt signaling, and bone formation in the
osteoblast lineage. In contrast, deletion of the UPR translational response regulator, PERK, suppressed
adipogenesis and stimulated adaptive UPR in osteoblastic cells. We therefore hypothesize that obesity impedes
skeletal repair by inhibiting IRE1 mediated osteogenesis and protracting PERK mediated translation arrest in
osteogenic progenitors. Studies in Aim 1 will determine if remediating adaptive IRE1 response, using genetic
and pharmacologic means, can restore Wnt-induced osteogenesis during skeletal repair of obese mice. Single-
cell profiling studies will be probe obesity-related changes in the ontogeny of bipotential osteoprogenitors.
Studies in Aim 2 will assess if chemically or genetically modifying PERK-regulated protein synthesis can restore
osteogenesis and viability of the callus. We will also determine if deleting PERK in preadipocytic subset of CAR
cells rescues their obesity-related translation arrest phenotype, callus adiposity and augments bone repair. We
will characterize the obesity-related translational reprogramming in Adipo-CAR cells and leverage -omics studies
in Aim 1 to discern mediators of crosstalk between PERK and adaptive IRE1 axes. Collectively, our studies will
uncover novel avenues of improving fracture healing in obesity.

Public health relevance
PROJECT NARRATIVE An aberrant Unfolded Protein Response (UPR), due to continued protein folding and processing overload in the endoplasmic reticulum (ER), is known to drive obesity-related co-morbidities. We found compelling evidence that UPR is dysregulated during osteogenic repair in obesity and may underlie poor fracture outcomes in obese individuals, that prolong disability and often necessitate surgical intervention. Using genetic and pharmacologic tools, this proposal will determine if targeting one or more response arms of the UPR in skeletal stem cells can alleviate the obesity-related fracture repair deficits.